NRSA Hepatology Training Grant

DESCRIPTION (provided by applicant): The Postdoctoral Training Program in Hepatology is an integral part of the robust liver-related research effort at UCSF. The purpose of the Program is to provide trainees a comprehensive background in liver biology and disease as well as the investigational skills to address new questions and contribute to new knowledge in hepatology. The Program is staffed by 13 faculty based within the Departments of Medicine, Surgery, Biochemistry and Microbiology & Immunology; collectively these individuals offer balanced expertise in basic and clinical hepatology and have a strong track record of working collaboratively with each other. A subgroup of 5 Program faculty comprise a Steering Committee charged with screening applicants, reviewing the training curriculum and monitoring the progress of active trainees. The top priority of the Program is to train physician- scientists who are admitted to UCSF as Gastroenterology fellows. MD applicants to the Program must have a prior record of research accomplishment and dedication to an independent investigative career in hepatology. PhD applicants are admitted largely from mentor laboratories; they must display similar academic promise and an orientation toward translational liver research. All trainees are placed through a core curriculum covering liver-related biology, liver-related research methods and general academic skills. They then undergo specialized research instruction under an individual mentor, with choices ranging from clinical epidemiology, health outcomes and genetics to cell biology, organogenesis, immunology, metabolism and fibrosis/carcinogenesis. Additional focused coursework is highly recommended for all trainees; for those pursuing clinical investigation, enrollment in a Master's Degree program is mandatory. Importantly, the Training Program benefits from numerous institutional resources including outstanding graduate programs in basic and clinical sciences as well as research support units such as the Liver Center and the Clinical and Translational Sciences Institute. Program faculty are strong figures in each of these units, and accordingly can guide trainees to utilize these resources to maximize the value of their postdoctoral experience. The ultimate goal of the Training Program is to provide sufficient group and individual mentorship to enable graduates to assume a faculty-level position and compete successfully for independent research funding in hepatology.

Public health relevance
Postdoctoral Training Program in Hepatology is designed to provide MD and PhD scientists the skills to conduct independent research relevant to the liver. The Program fills a need for basic and clinical investigators who will direct new scientific knowledge to the prevention, diagnosis and treatment of liver-related ailments. The Training Program enables faculty to provide focused research instruction to 4 trainees per year. Importantly, it also enables trainees to enroll in didactic courses and obtain an advanced degree. The ultimate goal of the Training Program is for graduates to become independent investigators, meaningful contributors to the field of hepatology, and hopefully mentors themselves. The expectation is that the trainees' research successes will translate into improved outcomes for patients suffering from liver diseases.